The impact of obesity on neutrophil swarming in septic surgical patients

Project Abstract
While obesity has been shown to increase mortality in sepsis, the mechanism underlying this phenomenon is
unclear. Dr. Jalilvand’s preliminary data demonstrates that obesity is associated with increased 90-day mortality
in surgical patients with sepsis. Further, we have shown that obese adipocytes produce distinct adipocyte-
derived extracellular vesicles (AdEVs) that activate neutrophils and induce disordered neutrophil swarming.
These AdEVs are enriched with miR-223, which interacts with PIK3C2A to downregulate the phosphoinositide-
3 kinase (PI3K) pathway, thus reudcing neutrophil migration and chemotaxis. The governing hypothesis for this
proposal is that AdEV-mediated delivery of miR-223 to peripheral neutrophils in obesity impairs neutrophil
swarming by modulating the PI3K pathway, thereby contributing to disrupted pathogen clearance in surgical
patients with sepsis. We will test this hypothesis with the following aims. AIM 1: Define the role of AdEV-mediated
delivery of miR-223 on PI3K activation and swarming in healthy neutrophils and the efficacy of targeting this
pathway to restore swarming in septic obese and lean patients in vitro. We will determine the in vitro differential
impact of modulating AdEV miR-223 content on neutrophil function and whether pharmacologic upregulation of
the PI3K pathway can restore swarming in neutrophils isolated from healthy and septic obese and lean
individuals. AIM 2: Establish the efficacy of inhibiting miR-223 mediated PI3K downregulation in neutrophils to
improve swarming and survival in obese mice with intra-abdominal sepsis. Using a murine model of diet-induced
obesity (DIO) and intra-abdominal sepsis (cecal ligation puncture, CLP), we will test whether systemic delivery
of AdEVs enriched with anti-miR-223 improves neutrophil function, bacterial clearance, and survival following
CLP in vivo. Lastly, using a conditional, neutrophil-specific knock out of PIK3C2A, we will establish whether
transient silencing of PIK3C2A mitigates miR-223-mediated downregulation of neutrophil PI3K activation and
swarming in DIO mice after CLP. While capitalizing on her PhD in adipose tissue inflammation and obesity, this
proposal represents a departure from both Dr. Jalilvand and her primary mentor’s, Dr. Hsueh, prior research
focus. A multidisciplinary approach has been crafted to study the proposed aims to develop Dr. Jalilvand’s
expertise in EV biology and cargo, live cell imaging to follow neutrophil behavior and quantitative function,
pharmacologic targeting, and murine models of sepsis. Completion of this proposal will provide crucial technique
expansion needed to establish a unique area of research distinct from Dr. Jalilvand’s PhD, accomplishing the
short-term goals of this career development plan. Paired with the institutional commitment to her success that
includes laboratory space, protected time, and laboratory funding, a well-established committee of mentors has
been selected to ensure that Dr. Jalilvand will achieve the long-term goal of becoming an independent surgeon
scientist evaluating the implications of obesity in surgical patients with sepsis. As such, this proposal will provide
Dr. Jalilvand with the requisite mentorship and resources to transition to independence.

Public health relevance
Project Narrative While obesity accounts for over 50% of septic surgical patients and is independently associated with 90-day mortality, the mechanism underlying how obesity modulates sepsis outcomes is lacking, particularly in surgical patients. This proposal will integrate mechanistic in vitro studies with sophisticated murine modeling of obesity and intra-abdominal sepsis to provide crucial data on possible therapeutic targets to mitigate the disparities in mortality between obese and non-obese septic surgical patients. This proposal has the potential to deliver fundamental insight into disease regulation and novel therapeutics to optimize sepsis management in a highly relevant clinical patient population.